Muscle ­bone interaction and its role in diabetic bone disease of Type I diabetes

Summary
Bone fracture incidence observed in individuals with Type 1 diabetes (T1D) is much higher compared to
the general population. The burden of diabetic bone disease is partially due to lack of evidence to support
targeted prevention and interventions to reduce fractures in this population. Furthermore, those with T1D
exhibit skeletal muscle dysfunction associated with decreased muscle strength and muscle mass. Skeletal
muscle and bone communication is a potential modifiable factor that may contribute to development of diabetic
musculoskeletal disease. More specifically, the candidate proposes that a myokine called myostatin, is directly
involved in development of diabetic bone disease and may associate with skeletal muscle dysfunction. The
role of myostatin in T1D and how it affects the musculoskeletal system in this disease are gaps in knowledge
that will be addressed with this proposal. Specifically, the three aims of this proposal are: 1. Quantify the
relationship between myostatin levels in serum and skeletal muscle, and bone parameters of humans with and
without T1D; 2. Quantify the relationship between myostatin levels in serum and muscle and the bone
phenotype of mice with insulin-deficient diabetes; 3. Evaluate whether inhibition of myostatin is beneficial for
prevention of DBD in insulin-deficient diabetes; and lastly 4: Determine the mechanism of action of myostatin
on osteoblastic bone cells under normoglycemic and hyperglycemic conditions. Myostatin, which is thought to
negatively affect both bone and skeletal muscle, may serve both as a marker of musculoskeletal function and
surrogate for risk for fracture in those with T1D. Additionally, it may offer an opportunity for targeted
intervention to prevent or improve musculoskeletal dysfunction associated with T1D. The knowledge gained
from these studies will set the ground for future studies in musculoskeletal health in diabetes and will offer the
candidate an opportunity to transition towards an independent career in the abovementioned field.
This proposal presents a five-year research career development program focused on the study of
muscle and bone interactions in Type 1 diabetes; and specifically, how muscle derived molecules, called
myokines contribute to diabetic bone disease, a serious and emerging complication of Type 1 diabetes. The
candidate currently holds a position as an Assistant Professor of Pediatrics in the Division of Pediatric
Endocrinology at the University of Kentucky. She has 75% protected time for research, independent office
space, laboratory space and access to all equipment and resources offered by the Barnstable Brown Diabetes
Center. The candidate is strongly committed to an academic career in the field of musculoskeletal research in
diabetes and is supported by her mentors and her department. The proposed study and the complementary
didactic work will provide the candidate with research skills in basic, translational and clinical research thereby
enabling to transition to an independent clinician scientist.

Public health relevance
Project Narrative Individuals with Type 1 diabetes have higher fracture rates and smaller and weaker muscles compared to those without diabetes, even in young ages. With this project we will try to identify whether a molecule that comes from skeletal muscle, called myostatin, is involved in the increased risk of fractures and the poor quality of skeletal muscle in young individuals with Type 1 diabetes.